PREVASTATIN EFFECT ON LIPOPROTEIN AND CHOLESTEROL METABOLISM IN DYSLIPIDEMIA

The purposes of the study is to evaluate the effect of 40 mg of prevastatin administered once daily in dyslipidemic (LDH cholesterol concentration >130mg/dl , triglyceride concentration > 90th percentile for age and HDL cholesterol concentration < 35mg/dl despite dietary intervention) patients with respect to plasma total cholesterol, LDL cholesterol, VLDL cholesterol, HDL cholesterol, and triglycerides. It is a randomized, double blind, placebo-controlled, crossover trial with a 6 week dietary lead in period.